Right Heart Function in Health and Chronic Disease

Right ventricular failure (RVF) is a serious clinical problem with a poor prognosis. However, specific treatment
options for RVF are very limited. Recent studies suggest that powerful cardioprotective effects are mediated by
α1-adrenergic receptors, in particular the α1A-subtype (α1A-AR). In the current funding period, we found that
chronic stimulation of α1A-ARs had major beneficial effects on RV function in two mouse models of RVF
induced by pulmonary fibrosis or pulmonary artery constriction (PAC). This renewal project will identify the
mechanisms involved in α1A-AR-mediated reversal of RVF and investigate if the beneficial effects of chronic
α1A-AR stimulation extend to beneficial effects in human cardiac muscle preparations.
This renewal project will build on the following preliminary results from the current funding period:
· In a model of RVF induced by PAC, RVF was reversed by chronic treatment with a highly specific α1A-
AR agonist (A61603), at a low dose that did not raise blood pressure.
· The beneficial effect of A61603 treatment involved increased signaling by the pro-survival kinase ERK,
increased BCL-2 (anti-apoptosis factor that protects mitochondria), increased myocardial ATP levels,
and decreased levels of reactive oxygen species (ROS), suggesting protective effects on mitochondria.
· RVF was associated with increased abundance of a novel intracellular isoform of matrix-
metalloproteinase-2: N-terminal truncated MMP-2 (NTT-MMP-2). NTT-MMP-2 expression was reported
to be induced by ROS and result in mitochondrial dysfunction, decreased ATP production and further
ROS generation. Our preliminary results show that A61603 treatment reduces NTT-MMP-2 in
mitochondria, and increased myocardial ATP, suggesting improved mitochondrial function.
· In the PAC model of RVF, chronic A61603 treatment decreased ROS, decreased ROS-mediated
modification of myofilament proteins and increased myofilament force development. Preliminary studies
using computational modeling suggest that increased myofilament force development is a critical factor
in the improved RV function resulting from A61603 treatment.
· We recently reported that the α1A-AR mediates a robust inotropic response in human RV myocardium
from heart failure patients and that α1A-AR-ERK signaling is present in failing human myocardium.
These findings suggest that the α1A-AR is present and functional in failing human RV and might be a
therapeutic target to induce cardioprotective effects in patients with RVF.
Hypothesis 1. For failing RV, chronic A61603 treatment rescues mitochondrial bioenergetic function,
resulting in increased ATP levels, reduced ROS generation and increased contraction.
Hypothesis 2. Rescue of mitochondrial bioenergetic function is mediated by reduced NTT-MMP-2 levels.
Hypothesis 3. Chronic α1A-AR stimulation is beneficial in human cardiac muscle preparations.
Aim 1. Determine if chronic A61603 treatment of RVF rescues mitochondrial bioenergetic function;
leading to increased ATP levels, reduced ROS levels, increased myofilament contraction and rescue of RVF.
Aim 2. Determine if rescue of mitochondrial function is mediated by reduced levels of NTT-MMP-2. We
will determine if chronic A61603 treatment of RVF reduces levels of NTT-MMP-2 and thereby rescues
mitochondrial function. We will determine if inhibiting NTT-MMP-2 experimentally rescues mitochondrial
function.
Aim 3. Determine if chronic treatment with A61603 has beneficial effects in human cardiac muscle
preparations. As proof of principle for translation to humans, we will determine if chronic A61603 treatment
has beneficial effects in two cardiac muscle preparations: engineered human heart tissue containing induced
pluripotent stem cell (iPSC)-derived cardiomyocytes, and cultured RV trabeculae from RVF patients.

Public health relevance
Heart failure and chronic obstructive pulmonary disease are extremely common in Veterans and commonly complicated by pulmonary hypertension and right heart failure. Treatment options for right heart failure are very limited. Heart failure has been the number one reason for admission among patients in the Veterans' Health Care System. Recent studies show that patients with post-traumatic stress disorder (PTSD) are at increased risk for cardiovascular disease, and PTSD is twice as prevalent in veteran populations versus the general population. The Department of Veteran Affairs Quality Enhancement Research Initiative (QUERI) is designed to improve care using research evidence to improve clinical practice for high-risk and/or highly prevalent diseases or conditions among veterans. Congestive heart failure is one of the high-risk, and highly prevalent diseases included in the QUERI program. Thus, research in cardiovascular disease, and RV failure in particular, are extremely important and relevant to the mission of the VA.